Metabolic Studies of Mouse Models of Obesity and Diabetes

The following projects have been supported by Mouse Metabolism Core in FY 2022:

1. DK075021
Role of G protein-coupled receptors in regulating glucose and energy homeostasis
Principal Investigator: Hans Jurgen Wess (LBC, NIDDK)

2. DK043313
Role of the Gnas Gene in Metabolic Regulation
Principal Investigator: Lee S. Weinstein (MDB, NIDDK)

3. DK043315
Role of Gs-alpha in central regulation of energy and glucose metabolism
Principal Investigator: Lee S. Weinstein (MDB, NIDDK)

4. DK043316
Role of Gs-alpha in regulation of adipose tissue growth and function
Principal Investigator: Lee S. Weinstein (MDB, NIDDK)

5. DK043317
Role of Gs-alpha in regulation of skeletal muscle metabolism
Principal Investigator: Lee S. Weinstein (MDB, NIDDK)

6. DK043318
Role of Gs-alpha in pancreatic islet cell growth and function
Principal Investigator: Lee S. Weinstein (MDB, NIDDK)
7. DK075056
Role of Gq/11-alpha in metabolic regulation
Principal Investigator: Lee S. Weinstein (MDB, NIDDK)

8. DK031117
Development of drugs acting at adenosine receptors
Principal Investigator: Kenneth A Jacobson (LBC, NIDDK)

9. DK075057 DEOB
Physiology and pharmacology of BRS-3 (Bombesin Receptor Subtype-3)
Principal Investigator: Marc L. Reitman (DEOB, NIDDK)

10. DK075062
Pharmacologic approaches to the treatment of obesity
Principal Investigator: Marc L. Reitman (DEOB, NIDDK)

11. DK075063
What can body temperature tell us about energy homeostasis?
Principal Investigator: Marc L. Reitman (DEOB, NIDDK)

12. DK075064
Role of brown adipose tissue (BAT) in energy balance
Principal Investigator: Marc L. Reitman (DEOB, NIDDK)

13. DK055106
Transforming growth factor - beta superfamily signaling in diabetes and obesity
Principal Investigator: Sushil Rane (DEOB, NIDDK)

14. DK055107
Cell cycle regulators in diabetes and obesity
Principal Investigator: Sushil Rane (DEOB, NIDDK)

15. DK075013
Nonalcoholic steatohepatitis: natural History, pathogenesis and therapy
Principal Investigator: Yaron Rotman (LDB, NIDDK)

16. DK043304
Mechanism of G Protein Beta5/ R7-RGS Protein/ R7BP Complex Signal Transduction
Principal Investigator: William F Simonds (MDB, NIDDK)

19. DK025061
Receptor Mediated Erythropoietin Metabolic Response and Gender Specific Activity
Principal Investigator: Constance T Noguchi (MCB, NIDDK)

19. BC005708
Xenobiotic receptors
Principal Investigator: Frank J Gonzalez (LM, NCI)

20. MH002386-35
Chemical Coding of Neurotransmission
Principal Investigator: Lee E Eiden (LCMR, NIMH)